PA22176, SBIR Phase I, Novel Automated Screening Approach for Identifying Fall Risk

Project Summary/Abstract
The proposed project relates to the development of a novel passive automated screening approach for identifying
fall risk in the elderly. Falls are the leading cause of both fatal and non-fatal injuries among adults age 65 and
older and the risk of fall-related death among older adults is increasing. Annually, 28.7% of older adults fall in the
United States, resulting in 300,000 hip fractures and over $70 billion dollars in medical costs in 2020. Improved
tools are needed to identify changes that increase fall risk. These tools are preferably, unobtrusive, automated,
entirely passive and deployable in the home environment. Recent research has described a novel technique for
eye tracking that is useful for identifying neuropathologies. This approach is feasible for inexpensive deployment
in the home using entertainment platforms as the foundational instrument for passively conducting the
examination. The objective of this project is to develop and evaluate a prototype system using this approach. A
prototype system will be specified, designed, tested, and evaluated in a human trial.

Public health relevance
Project Narrative Falling in older adults is a serious public health issue; one in three adults over 65 is reported to fall at least once each year. The proposed projects seek to develop an unobtrusive, automatic home-based system that evaluates changes in brain function that may lead to an increased risk of falling. Patients identified to be at increased fall risk will be referred to their doctor for a full examination and, if appropriate, a plan to make them safer in their home.